Activated Protein C for Treatment of Radiation Combined Injury

Program Director/Principal Investigator (Last, First, Middle): Weller, Hartmut Use only if additional space is needed to list additional